Global HIV Implementation Science Research Training Grant

PROJECT SUMMARY/ABSTRACT
While the scale of the HIV epidemic remains large, it has entered a promising new phase, marked by
unprecedented progress and opportunities. In view of the need to rigorously test interventions to improve the
uptake, implementation, and translation of recent scientific findings into standard of care (the know-do gap), as
well as to evaluate the impact of bringing such interventions to scale, in 2014 we launched a research training
program focused on Global HIV Implementation Science. Implementation science is the scientific study of
methods to promote integration of research findings and evidence-based interventions into health care policy
and practice, thus improving equity, quality and effectiveness of health services. A key element of translational
research, implementation science encompasses a broad range of skills, including epidemiology, biostatistics,
sociology, decision science, and health economics.
The long-term objective of the Training Program is to prepare well-qualified individuals for careers as
independently-funded researchers and for leadership in global HIV implementation research. We have
assembled an outstanding group of diverse faculty from multiple schools, departments, and centers at
Columbia University as well as from highly reputable international institutions. Our Training Program faculty
have distinguished themselves in mentorship and are leading cutting edge implementation science research
addressing HIV prevention among key and priority populations, including adolescent girls and young women,
men who have sex with men, and transgender people; engaging adolescents and men in the care continuum;
TB/HIV service integration; and differentiated service delivery. The Training Program encompasses
streamlined coursework based on an individualized training plan; weekly faculty-fellow seminars; tailored
mentorship; research experience in a variety of domestic and international field settings; presentations;
manuscript and grant preparation; research seminars and colloquia; and instruction in the responsible conduct
of research and methods for enhancing rigor and reproducibility in research. The Training Program also
includes rigorous evaluation of the quality and effectiveness of the Training Program, to ensure that trainees
achieve the competencies and skills necessary for success as future leaders in HIV implementation science
research.
The five-year program aims to support six predoctoral trainees at any given time. Trainees are required to
pursue a doctoral degree in Epidemiology and are supported for three years. With stellar faculty, a unique
training environment, and unparalleled research opportunities in domestic and international field settings, we
are well-poised to continue to lead this novel effort and nurture new investigators trained in multidimensional,
interdisciplinary approaches to advance scientific knowledge and demonstrate the impact of interventions.

Public health relevance
PROJECT NARRATIVE Despite recent advances in prevention and treatment, the scale of the HIV epidemic remains large. The Global HIV Implementation Science Research Training Program aims to increase the number of independent investigators with the knowledge and skills needed to rigorously test interventions to improve the uptake, implementation, and translation of recent scientific findings into standard of care (the know-do gap), as well as to evaluate the impact of bringing such interventions to scale. With stellar faculty, a unique training environment, and unparalleled research opportunities in domestic and international field settings, we are well-poised to continue this novel effort and nurture new investigators trained in multidimensional, interdisciplinary approaches to advance scientific knowledge and evaluate the impact of interventions which address this public health challenge.